Expanding the uSafeUS Mobile App to Reduce Alcohol-Involved Sexual Assault on College Campuses

PROJECT SUMMARY
This R34 application aims to develop and test an innovative mobile application (app) to reduce college student
drinking and sexual assault risk in real time. Over 75% of campus sexual assaults involve alcohol, yet existing
campus alcohol and SA prevention efforts designed for universal delivery are often siloed and limited in their
ability to provide students with in-the-moment assistance to reduce risk. Smartphone apps are an integral part
of college student life and are increasingly used to engage students in real-time alcohol prevention; however,
none have integrated alcohol and sexual assault prevention into a single cross-cutting tool. This study
addresses this gap by expanding a promising campus sexual assault prevention and response app
(uSafeUS®) to include evidence-based alcohol harm reduction tools and real-time messaging to support
students’ use of protective behavioral strategies (PBS) in the moments when they most need them. The
uSafeUS app, currently in use on 24 US college campuses, utilizes sexual assault PBS (e.g., sharing current
locations and an expected return home time with trusted peers) as the primary risk reduction mechanism for
students to use in social contexts where alcohol is present, yet none of the existing features directly address
alcohol consumption. This project will leverage the existing uSafeUS infrastructure and a proven user-centered
development process to expand app features to include an interactive drink tracker and personalized feedback
messaging to reduce alcohol consumption and increase PBS use. The expanded app (uSafeUS+) will be beta
tested in an open trial to gather end-user (student) and campus administrator feedback about the app’s
practical utility in the field and feasibility of the proposed implementation and evaluation plans. This will be
followed by a pilot 3-arm randomized controlled trial (N = 90, 30/arm) to examine the acceptability, feasibility,
and initial efficacy of uSafeUS+, relative to active (uSafeUS) and assessment-only control groups. In the short
term, results from the current study will optimize the planned app and inform a fully powered multi-site hybrid
effectiveness-implementation trial. Longer term, findings have the potential to inform the use of mHealth
approaches for integrating prevention tools to universally deliver personalized real time prevention on college
campuses where heavy drinking and sexual assault often co-occur.

Public health relevance
PROJECT NARRATIVE The proposed study extends a line of research that seeks to reduce alcohol-involved sexual assault on college campuses by developing the first smartphone application to integrate evidence-based alcohol and sexual assault prevention tools, making them accessible 24/7 for students to use in the moments when they are most needed. This study will use multiple rounds of feedback from students, student service providers, campus administrators, and subject matter experts to develop the app and then test its feasibility in a pilot randomized clinical trial. Findings will provide support for a full-scale test of the app’s impact and lay the groundwork to universally deliver real-time prevention tools to reduce alcohol-involved sexual assault on college campuses.